Determining the influence of sex and gender in hepatocellular carcinoma risk and survival

PROJECT SUMMARY/ABSTRACT
Hepatocellular carcinoma (HCC) is the fastest rising cause of cancer-related death in the U.S. and a leading
cause of death in patients with cirrhosis. Men are disproportionately affected, with 2-8 times higher incidence
and mortality rates than women globally, across time periods and all racial and ethnic groups. Despite this
consistent observation, the extent to which sex- (i.e., biologic) and gender-related (i.e., social, behavioral)
factors contribute to disparities in HCC risk and survival are unknown. Further, sex disparities in HCC
incidence have yet to be investigated in patients with cirrhosis – the main at-risk cohort in the U.S. This
application adapts the Warnecke conceptual model to articulate specific sex- and gender-related factors that
have not previously been explored for disparities in HCC. This model is then applied to 3 large multicenter
cohorts of patients with cirrhosis and HCC – all with unique clinical and survey data and stored serum samples.
The central hypothesis that disparities in HCC risk are primarily influenced by sex-related biologic factors,
whereas disparities in HCC survival are driven to a greater extent by gender-related social and behavioral
factors, will be investigated through the following Specific Aims: 1) Estimate the association between sex-
related factors and HCC risk in >4,000 patients with cirrhosis; 2) Quantify the magnitude of the survival
disparity between men and women with HCC; 3) Evaluate the influence of sex- and gender-related factors on
HCC survival. Data from the project aims will be triangulated to inform an intervention to reduce disparities in
HCC. The PI is a clinical researcher and hepatologist at UT Southwestern, with a long-term vision of tackling
cancer health disparities and improving care for patients with HCC. The proposed training plan is integrated
with the research aims and builds on her existing knowledge in clinical research and epidemiology. She has
assembled an exceptionally talented interdisciplinary team of mentors with complementary expertise: Dr. Amit
Singal, experienced health services researcher and content expert in HCC; Dr. Carolyn Mazure, internationally
recognized expert in the study of the influence of sex and gender on health; Dr. Katherine McGlynn,
epidemiologist with expertise in sex hormones in cancer; and Dr. Jasmin Tiro, behavioral scientist with
expertise in mixed methods research. The PI will acquire new, advanced skills in understanding the influence
of sex and gender in health, advanced quantitative analyses, mixed methods research, and knowledge
synthesis to inform intervention development. The research studies in this proposal have significant public
health impact as they will fill gaps in our understanding of the influence of sex and gender on HCC disparities
and expand what is known about HCC in women, a population underrepresented in HCC research. This award
and career development plan will provide the PI with the protected time, training, mentorship, and experience
to build an independently funded research career focused on reducing health disparities in patients with liver
disease and HCC.

Public health relevance
PROJECT NARRATIVE Hepatocellular carcinoma (HCC) is a highly fatal cancer accounting for over 780,000 deaths annually, and while men have consistently higher HCC risk and worse survival compared to women, we do not have an adequate understanding of why this disparity exists. We will apply a conceptual framework to three large multi- center patient cohorts to identify specific sex- (i.e. biologic) and gender-related (i.e. social, behavioral) factors that influence disparities in HCC incidence and prognosis. This proposal will yield critical data to inform future interventions to reduce disparities and improve survival for both men and women with HCC.